Interactions Between Spatial and Temporal Cues for Auditory Grouping in Normal Hearing and Single-Sided Deaf Populations

Project Summary/Abstract:
In real-world listening environments, individuals must integrate distinct auditory features such as pitch, onset
time, and spatial location to perceive auditory objects amidst background noise. This feature integration is
particularly important for deciphering sequential sounds with converging features, such as speech or music.
Hearing loss, especially in single-sided deafness (SSD), can disrupt feature integration leading to challenges
like impaired speech comprehension in noise. This study adapts a perceptual illusion, the auditory kappa (AK)
effect, to investigate feature integration in the healthy and impaired auditory system. In the AK effect, changes
in pitch bias relative timing judgments in sound sequences such that sequential tones that are closer in pitch
are perceived as closer in time. Leveraging this effect, we introduce the auditory spatial kappa (ASK) task to
investigate how acoustic spatial and temporal cues are integrated to bias time perception and to test the effect
of SSD on spatio-temporal feature interactions underlying auditory object perception, with and without a
cochlear implant (CI). While temporal onsets are preserved in CI signal processing, individuals with CI and
SSD face unique challenges due to impairments in spatial localization and auditory stream segregation.
Although SSD patients recover some sound localization abilities with CI, it is crucial to identify disruptions in
spatio-temporal features binding in this population. Our research objectives include establishing spatio-
temporal feature interactions in normal hearing (NH) adults and determining which cues for spatio-temporal
auditory perception are restored with CI in the SSD population. Aim 1 establishes baseline measures of spatial
biases on timing judgments in NH adults. Participants will report the relative timing of sequential sounds
presented at distinct horizontal locations. Building on our previous research studying the AK effect and
preliminary data, we predict an ASK effect where smaller spatial separations result in shorter perceived time
intervals due to auditory grouping. We hypothesize that grouping sounds based on spatial proximity biases
perceived temporal proximity. Aim 2 examines the effect of SSD on this task and determines the extent of
restored spatio-temporal feature interaction in SSD patients with CI. The ASK task will be adapted to compare
fine-grained localization and more coarse lateralization in SSD individuals with and without CI. Based on
preliminary data, we predict poor localization performance and a lack of feature interaction, measured as
perceptual bias, without CI and a bias restoration for higher frequencies with CI due to reintroduction of
bilateral interaural level cues. Findings from this research may provide an easy, objective measure of feature
integration for auditory training tasks and improve rehabilitation strategies, especially in addressing challenges
like speech comprehension in noise. Furthermore, this study will test the ASK task as an easy, quick clinical
test of spatial cue restoration for SSD-CI patients. Overall, the project contributes to advancing knowledge in
auditory perception and has potential implications for clinical applications and rehabilitation efforts.

Public health relevance
PROJECT NARRATIVE In everyday listening environments, integrating multiple acoustic features is crucial for auditory object perception and stream segregation, yet there is a gap in our understanding of how various spatial and temporal cues are integrated to influence perception in healthy and impaired auditory systems. This project adapts a pitch-based auditory illusion to the spatial domain to investigate spatio-temporal feature integration, examining the biasing effects of sound source location on the perception of relative timing among sequential sounds in normal hearing and single-sided deaf (SSD) adults. The public health significance of this project lies in establishing a simple, innovative task for assessing auditory spatio-temporal feature integration to serve as a more specific functional marker of real-world localization performance than current clinical tasks, and applying this task to SSD patients with and without a cochlear implant (CI) to determine the nature of auditory spatial cue restoration with CI.